Striatal Interneuron Contributions to Behavioral Control

Extensive work suggests the input nucleus of the basal ganglia, the striatum, is an essential site in filtering and
amplifying behaviorally relevant inputs to shape motor output according to outcome. This filtering occurs via
competitive control of striatal spiny projection neuron (SPN) activity by widespread excitatory projections from
cortex, thalamus, and amygdala, which is reinforced by striatal dopaminergic signaling that encodes deviations
from expected outcomes. Another understudied, yet potentially crucial circuit element in this initial input filtering
are local striatal interneurons, which can be subdivided into subtypes dependent on synaptic connectivity,
intrinsic properties, and molecular diversity. Despite their scarcity compared to SPNs, recent work suggests they
can strongly modulate striatal SPN output and behavior. Our lab has previously discovered a role for striatal low
threshold spiking interneurons (LTSIs), which target SPN dendrites, in controlling acquisition of early
instrumental learning. However, functions outside of initial learning have not been investigated. Another striatal
interneuron subtype, tyrosine hydroxylase-positive interneurons (THINs) - which despite their weak expression
of this enzyme do not release dopamine – participate in local inhibitory control of LTSIs and SPNs in in vitro
preparations and may maintain goal-oriented operant choice in vivo. Despite some recent successes, our
understanding of how local striatal interneurons support complementary computational functions for motor
control has been slowed by the absence of consistent behavioral frameworks in which to compare subtypes.
Here we address this limitation by combining a modular, head-fixed value-based choice task with viral-genetic
tools to systematically examine striatal LTSI and THIN contributions. We hypothesize that LTSIs and THINs
encode and control distinct components of value-based choice via striatal interactions, including how choices
are selected and executed. To test this, we first use population calcium imaging of each subtype together with
behavioral modeling that captures latent value signals to understand what parts of value-based behavior each
cell type represents. Next, we test the causal contributions of these subtype-specific activity patterns by using
bi-directional optogenetic manipulations at two timepoints – in the pre-choice decision epoch and in the outcome
epoch, when the results of actions are used to inform future choice. To map the synaptic connectivity of LTS and
TH interneurons within the local striatal circuit, we use in vitro acute slices with optogenetic recruitment of specific
interneurons together with paired subtype-specific SPN recordings. Finally, we combine in vivo optogenetic
striatal interneuron manipulations together with extracellular recordings of SPNs to test the hypothesis that
interneuron effects are in part determined by behavioral context dependent SPN interactions. Together, this
proposal provides a comprehensive approach to understand how different striatal interneuron populations
contribute to the filtering processes at the center of striatal control of motor behavior.

Public health relevance
The striatum is an evolutionarily conserved structure essential for the filtering and amplification of brain-wide projection inputs that mediates planning, action, attention, and reinforcement. Our prior work has shown that striatal interneurons can impact local circuits and strongly shape action, specifically early learning. This proposal uses genetic/viral techniques, rigorous behavioral analyses, recording of neural signals via in vitro acute slices, in vivo Ca2+ imaging and extracellular electrophysiology, as well as temporally precise manipulations of neural activity to investigate how two unique interneuron subtypes play differential roles in the processing of value- based decisions.